PROGRAM MANAGEMENT, TRAINING SUPPORT AND TECHNICAL SERVICES FOR HIGHLY COMPLEX SYSTEMS

The contractor will provide support to ITAC, the OM Project Management Office and Office of Workforce Development in the areas of Program and Project Management and workforce development. The Contractor shall develop and deliver a comprehensive training program in the program and project management of highly complex scientific programs.